EVALUATION OF MOLECULAR MECHANISMS OF TREATMENT RESPONSE IN LATE LIFE DEPRESSION

DESCRIPTION: Over the past decades, antidepressants and psychotherapy have been the first-line
treatments for LLD. Despite being safe and well-tolerated, a large number of patients do not achieve full and
persistent remission after initial treatment. About 50% of patients with LLD do not respond after two
antidepressant trials, meeting the consensus definition of treatment resistance (TR-LLD). The persistence of
chronic and elevated depressive symptoms in older adults has significant clinical and public health
implications. This has been correlated to poor general health, reduced quality of life, and a higher risk of
mortality when compared to those with sustained remission after treatment. Despite the relevance to public health
of TR-LLD, there is little information about the biological mechanisms and no robust clinical prediction model to
evaluate at the outset of antidepressant therapy who will or will not respond to treatment.
Leveraging an NIMH funded clinical trial, the Incomplete Response in Late-Life Depression: Getting to
Remission” (IRL-GREY), across 3 sites, in this study, we propose to evaluate the biological mechanisms
related to treatment response in late-life depression and to develop a machine learning based algorithm for
prediction of treatment response in these subjects. We will carry out a comprehensive, multiplexed proteomic
analysis on 542 samples from patients who completed phase 1 and phase 2 of the clinical trial. We
hypothesise that ageing-related biological pathways (i.e. inflammatory response control, proteostasis control,
cell damage response, endothelial function) will be associated with poorer treatment response in LLD.
Moreover, we hypothesize that a machine learning derived biomarker panel will have sensitivity and specificity
greater than 80% to predict treatment response in LLD. Finally, we will evaluate the biological mechanisms
related to different depressive symptoms trajectories after treatment.
This work will set the stage for a biologically-driven model of treatment response that will be useful to guide, at the
outset of antidepressant treatment, those who will benefit more from a specific treatment. If successful, our work
can accelerate therapeutic efforts and innovation targeting depression and reduce suffering for large numbers of
elderly and their families.

Public health relevance
Using advanced molecular approaches, we will determine the biological mechanisms related to treatment response in late-life depression. Our proposed study will also develop a predictive tool combining neurocognitive, neuroimaging, and protein data to identify who with late-life depression is more likely to have no benefit from antidepressant treatment at the outset of therapy. The goal of the study is to clarify the mechanisms of treatment response in late-life depression, and whether we can effectively identify those who will benefit from antidepressant therapy at the outset of treatment.